A Randomized, Double-Blind, Placebo-controlled Clinical Trial of Choline Supplementation during Pregnancy to Mitigate Adverse Effects of Prenatal Alcohol Exposure on Growth and Cognitive Development

Abstract
Although the adverse effects associated with prenatal alcohol exposure (PAE) are well known, many women
continue to drink heavily during pregnancy, putting their infants at risk for fetal alcohol spectrum disorders.
Given the limited effectiveness of psychosocial and informational interventions, there is a growing interest in
new approaches, such as nutritional interventions, that may be more effective. Animal studies have shown that
choline supplementation during the equivalent of the 3rd trimester in humans can mitigate effects of PAE on
growth and development. However, findings from studies in humans to date have been inconsistent and
difficult to interpret. Choline, an essential nutrient, serves as a methyl-group donor for DNA methylation and is
a constituent of the neurotransmitter acetylcholine and a precursor to major components of cell membranes. In
an R21 feasibility trial, 70 heavy drinkers were randomly assigned to receive a daily dose of 2g of choline or a
placebo from time of enrollment in antenatal care until delivery. Participants were recruited from the Cape
Coloured (mixed ancestry) community in Cape Town, South Africa, where the incidence of heavy drinking during
pregnancy and fetal alcohol syndrome are among the highest in the world. Infants in the choline-treated arm
were more likely to meet criterion for eyeblink conditioning than those in the placebo arm. Infants born to both
the choline- and placebo-treated mothers were small at birth, but those in the choline arm showed
considerable catch-up growth in weight and head circumference by 6.5 mo, which persisted through 12 mo. At
12 mo, infants in the choline arm showed markedly better recognition memory compared to placebo-treated on
the Fagan Test of Infant Intelligence, which is known to have predictive validity for school-age IQ. Key features
of this study included the higher choline dose (4.4 times adequate intake (AI), compared to 1.7-2.5 in previous
human studies) and initiation of treatment early in pregnancy. We propose to recruit heavy drinking pregnant
women from a rural Cape Coloured community to participate in a fully-powered, double-blind, randomized,
placebo-controlled choline supplementation trial (1) to assess the effectiveness of maternal choline
supplementation during pregnancy to mitigate effects of PAE on three primary outcomes: infant recognition
memory and postnatal growth restriction (weight and head circumference); (2) to assess the efficacy of this
supplementation for mitigating alcohol effects on the following secondary outcomes: infant eyeblink
conditioning, postnatal length, and information processing speed; (3) to use innovative methods from causal
inference analysis to examine protocol adherence as an important source of variation in treatment efficacy and
to identify socio-demographic factors associated with non-compliance in order to facilitate implementation of
the intervention protocol in clinical settings; and (4) in exploratory analyses, to examine whether maternal
choline supplementation is particularly effective in women with lower dietary choline intake or poor nutritional
status.
!

Public health relevance
Public Health Relevance Given the limited effectiveness of informational and psychosocial interventions in addressing the continuing major health risks associated with maternal heavy alcohol consumption and binge drinking during pregnancy, there is growing interest in new approaches, such as nutritional interventions, that may be more effective in reducing the risks associated with fetal alcohol spectrum disorders (FASD). Extensive data from animal studies and preliminary data from our R21 maternal choline supplementation feasibility study suggest that daily supplementation with a high dose of the nutrient choline initiated early in pregnancy can be effective in mitigating a range of adverse effects on growth and neurobehavioral function seen in FASD. The proposed fully-powered, phase II, double blind, randomized placebo-controlled trial is designed to confirm these findings, thereby providing the basis for implementation of this promising, highly innovative intervention in clinical settings.